Wireless power transmission for implantable devices

[unreadable] DESCRIPTION (provided by applicant): A clear need exists for the development of advanced power sources and recharging protocols for implanted electro-medical devices. The useful lifetime of most implants is constrained by the longevity of the power source. Pacemaker and other implantable battery replacement procedures are expensive, cause patient distress, and have the potential for causing infections. Many new and emerging medical device technologies, such as enhanced inter-device telemetry, automated wireless alarm signaling, advanced sensors, and infusion pump therapies, continue to place demands on power. A novel new method for recharging secondary batteries can provide significant advantages over the infrequently used currently method. A wireless power transmission method based on the principle of ultrasound technology is being developed. The concept is made feasible by the development of PMN-PT, an advanced material that exhibits significant potential for transforming acoustic to electrical power. The potential advantages include much smaller transmitters and receivers, receivers that can be embedded in devices, and elimination of electromagnetic interference and metal heating. The goal is to demonstrate the feasibility of significant wireless power transfer to sites within the body using this material. Specific aims include designing the receiver, making the material with the correct properties, fabricating the receiver, developing the circuitry to mate it to the implantable battery, confirming useful power transmission levels experimentally, meanwhile being careful to adhere to accepted FDA ultrasound safety guidelines. [unreadable] [unreadable] [unreadable]